Down Syndrome: a potential treatment XISTs

Summary
Down syndrome arises from the triplication of a subset of genes on chromosome 21 (HSA21). Individuals with
DS uniformly demonstrate some degree of mental retardation (MR). The MR has been attributed to
impairments in brain development (i.e. neurogenesis) as well as progressive cell death with altered
synaptogenesis (i.e. neurodegeneration). Silencing of one of the three HSA21 chromosomes rescues the DS
phenotype but such a therapeutic approach is limited practically by the efficiency of genomic editing and ability
to specifically target a single HSA21 chromosome. With prior funding from NIH INCLUDE, we have developed
a novel modified CRISPR approach which greatly enhances the integration of genomic material on HSA21 and
we have also devised a means with which to specifically target a single HSA21 copy by SNP based PAM
targeting with gRNA. Feasibility has been shown in culture model systems. We now propose experiments to
assess the efficiency of these approaches in the TcMAC1 mouse model of DS. The TcMAC21 mouse contains
93% of HSA21q protein coding genes that are expressed and regulatable. Overall, if successful, these studies
would show the potential ability to reverse, at least partially, the DS neurological phenotype.
The funded proposal is the necessary next step to ascertain whether the efficiency of silencing by XIST of a
third HSA21 copy in vivo would translate into an observable clinical effect.

Public health relevance
Narrative Down Syndrome (DS) is caused by a triplication of genes on chromosome 21 (HSA21) and gives rise to mental retardation (MR). Silencing of one of three copies of HSA21 has been shown to rescue the cell phenotype. In our prior funded work, we have developed several approaches to overcome the technical hurdles to allow for therapeutic intervention – efficient genomic integration and specific targeting of one of the three HSA21 chromosomes. The current proposal seeks to address whether enhanced efficiency of silencing seen in vitro can be achieved in vivo. After lentiviral based infection of the targeting construct into the TcMAC21 DS mouse model, we will evaluate whether these mice show normalization in phenotype at the behavioral, neurophysiological, histological and genetic/epigenetic levels.